Hybridization Chain Reaction: In Situ Amplification for Biological Imaging

Project Summary
Hybridization Chain Reaction: In Situ Ampliﬁcation for Biological Imaging
Life is orchestrated by programmable biomolecules – DNA, RNA, and proteins – interacting within complex biolog-
ical circuits. RNA in situ hybridization (RNA-ISH) methods provide biologists with a crucial window into the spatial
organization of this circuitry, enabling imaging of mRNA expression in an anatomical context from subcellular to
organismal length scales. Due to variability between specimens, examination of detailed spatial relationships
requires multiplexed experiments in which multiple target mRNAs are imaged with high resolution within a single
biological sample. Using traditional RNA-ISH methods in thick autoﬂuorescent samples including whole-mount
vertebrate embryos, multiplexing is cumbersome or impractical, spatial resolution is frequently compromised by
diffusion of reporter molecules, and staining is non-quantitative. The same drawbacks apply using traditional
immunohistochemistry (IHC) methods to image protein expression in these challenging samples, while with tradi-
tional DNA in situ hybridization (DNA-ISH) methods, it is not currently routine to image single-copy small genomic
loci in any sample, much less in vertebrate embryos. These longstanding shortcomings of traditional ISH and
IHC methods are a signiﬁcant impediment to the study of genetic regulatory networks in systems most relevant
to human development and disease.
In situ ampliﬁcation based on the mechanism of hybridization chain reaction (HCR) draws on concepts from
the emerging discipline of dynamic nucleic acid nanotechnology to achieve three mRNA imaging breakthroughs
in whole-mount vertebrate embryos and thick tissue sections: straightforward 5-channel multiplexing, subcellular
relative quantitation, and single-molecule resolution and sensitivity. The proposed research will build on these
unique capabilities to dramatically advance the robustness, multiplexing, and quantitation capabilities of HCR for
RNA-ISH and to extend the beneﬁts of multiplexed, quantitative, enzyme-free HCR signal ampliﬁcation to IHC
and DNA-ISH in thick autoﬂuorescent samples. Major goals are:
In situ HCR v3.0: automatic background suppression using cooperative probes for next-generation robust-
ness and signal-to-background imaging mRNAs and short RNA targets (miRNAs, mRNA splice junctions,
and closely related RNA sequences) in diverse organisms.
Next-generation multiplexing (15-plex with simultaneous HCR signal ampliﬁcation for all targets) and quan-
titation (high-ﬁdelity mRNA absolute quantitation with subcellular resolution and whole-embryo scale).
Next-generation versatility: extend the beneﬁts of HCR imaging to protein targets, single-copy small ge-
nomic loci, and molecular complexes, enabling compatible multiplexed imaging of all target classes.
Realization of these goals would have a broad impact on research in the biological sciences, providing an un-
precedented combination of multiplexing, quantitation, resolution, sensitivity, and versatility for the study of genetic
regulatory networks in an anatomical context.

Public health relevance
Project Narrative Hybridization Chain Reaction: In Situ Ampliﬁcation for Biological Imaging We propose to engineer molecular technologies with unprecedented capabilities for simultaneously and quan- titatively imaging DNA, RNA, and protein molecules within intact vertebrate embryos and thick tissue sections, providing biologists with crucial tools for elucidating the molecular underpinnings of human development and disease.